Next-generation genetic engineering of the pan-leukocyte antigen CD45 to facilitate CAR-T cell therapy against hematologic malignancies

SUMMARY/ABSTRACT (PROJECT 2): Next-generation genetic engineering of the pan-leukocyte
antigen CD45 to facilitate CAR-T cell therapy against hematologic malignancies
Currently, chimeric antigen receptor (CAR)-T cells must be individually designed for each disease, targeting
lineage-associated antigens such as CD19 for B-cell malignancies or BCMA for myeloma. While this approach
has led to the successful treatment of hundreds of patients on clinical trials or with commercial CAR-T cell
therapies, from a drug development standpoint this approach is inefficient. By targeting a pan-hematologic
antigen, a single “drug” could be used for all indications, thereby accelerating clinical research. CD45 is a
receptor tyrosine phosphatase that is expressed on the surface of most hematopoietic cells, from immature stem
cells to differentiated progeny. As expected, antibody-drug conjugates targeting CD45 cause profound
myeloablation and are in clinical development as conditioning agents prior to stem cell transplantation. A unique
hurdle limiting the use of anti-CD45 CAR T cells (CART-45) is that T cells themselves express CD45, and CART-
45 are therefore vulnerable to fratricide. Furthermore, CD45 is crucial for proper function of the T cell immune
synapse. The overarching goal of this project is to render CD45 targetable using genetic engineering of
T cells and of hematopoietic stem cells (HSC). To achieve this goal, we will test the central hypothesis that
site-specific mutation of CD45 in hematopoietic cells (including T cells) can abrogate recognition by CART-45
while retaining all other domains required for the function of this molecule. We expect that this approach will
prevent T cell dysfunction and myeloablation. This will be accomplished in three specific aims. In Aim 1, we will
generate fratricide-resistant CD45-targeting CAR-T cells. We have identified a candidate CAR construct based
on unbiased functional screening and shown that CART-45 are indeed subject to fratricide. While this fratricide
could be rescued by CRISPR-based knock out of CD45, CD45-deficient CART cells were dysfunctional. Using
alanine mutagenesis, we then identified the target epitope on CD45 that is recognized by our lead CAR candidate
and we have now successfully edited this epitope to abrogate fratricide, resulting in CAR-T cells that recognize
native CD45 in trans without themselves being the target of anti-CD45 CAR. In this aim we will test the hypothesis
that the function of CD45-edited T cells is equivalent to unmodified control T cells, and superior to that of CD45-
deleted T cells. In Aim 2, we will genetically engineer hematopoietic stem cells to generate a CART-resistant
hematopoietic system. To demonstrate that engineered CD34+ HSC’s are resistant to CD45 targeted CAR-T
cell therapy, engineered HSPC’s will be engrafted into immunodeficient mice followed by treatment with CD45
CAR-T cells. Finally, to target CD45 in human AML we will disrupt CD45 expression in primary human AML and
test leukemogenicity in vitro and in vivo. In Aim 3 up to 6 patients will undergo allogeneic stem cell transplantation
using donor stem cells where CD45 expression has been edited using CRISPR/Cas9, followed by infusion of
donor-derived CART-45. Successful completion of this Aim will provide proof-of-concept for our overall strategy
to create a leukemia-specific antigen using gene editing tools.

Public health relevance
NARRATIVE (PROJECT 2) This proposal seeks to bring the power of genetically-modified T cell therapy to the treatment of patients with AML using cutting edge genetic engineering approaches. The proposed research is relevant to public health because it addresses the challenges facing physician-scientists in the quest to find and use cancer-specific antigens for immunotherapy and is relevant to those parts of the NCI’s mission that pertain to eliminating suffering and death due to cancer. This work is expected to open new therapeutic horizons in the field of adoptive immunotherapy for AML and new research horizons that could be translated to other malignancies by combining CART cell therapy with gene editing.